CYCLOTRON PRODUCED ISOTOPES IN BIOLOGY &MEDICINE: PET RADIOPHARM

The chemistry core of the cyclotron project is aimed at the development of new radiophamaceuticals for use in positron emission tomography. A major usage of the mass spectrometry facility is in the characterization of new compounds. We typically produce new fluorinated or methylated derivatives of lead pharmaceuticals. These are then screened for the desired biological activity. Mass spectrometry plays a fundamental role in assisting with characterization of these materials.